ECT2 Isoform Switch in Pancreatic Cancer.

PROJECT SUMMARY/ABSTRACT
Epithelial Cell Transforming Sequence 2 (ECT2) is a guanine nucleotide exchange factor that activates the
function of RHO family GTPases. ECT2 expression is induced and prognostic in pancreatic ductal
adenocarcinoma (PDAC), one of the deadliest cancer types. Our goal is to define the role of ECT2 in PDAC
transformation. Two major ECT2 mRNA variants (ECT2-Ex4+ and ECT2-Ex4-) have been shown to express in
cells through alternative splicing events that include or exclude exon 4 of the ECT2 gene. Our preliminary data
indicate that: 1) ECT2 expression is elevated in PDAC precancerous lesions and PDAC tumors; 2) the ratio of
ECT2-Ex4+ to ECT2-Ex4- expressed is elevated in primary PDAC tumors and cell lines when compared to
normal pancreas cells and tissues; 3) an elevated ECT2-Ex4+ to ECT2-Ex4- ratio correlates clinically to poorer
survival rates in PDAC patients; and 4) ECT2 is required for PDAC cell transformation. We hypothesize that
the ECT2-Ex4+ isoform is oncogenic in PDAC and may serve as a biomarker of PADC progression and
novel therapeutic target. This hypothesis will be tested through completion of three interrelated specific aims
designed to: 1) determine the status of ECT2-Ex4+ in PDAC precursor lesions and PDAC tumors in situ; 2)
define the specific role of ECT2-Ex4+ in normal pancreas cells and PDAC tumor growth and metastasis; and 3)
determine the role of ECT2 exon 4 on ECT2 oncogenic signaling in PDAC cells. Successful completion of these
studies will provide new insight into the role of ECT2 in PDAC transformation and enhance our understanding of
PDAC progression. In addition, our studies will facilitate the development of a novel biomarker for early PDAC
diagnosis. Finally, our studies may reveal an ECT2 isoform switch as a novel therapeutic vulnerability in PDAC.

Public health relevance
PROJECT NARRATIVE The ECT2 protein has been shown to be overexpressed and prognostic in pancreatic ductal adenocarcinoma (PDAC), a deadly cancer characterized by its late stage detection, poor prognosis, and poor therapeutic response. This proposal will use novel isoform specific tools to determine the importance of an ECT2 isoform in PDAC onset and progression, and contribution in normal pancreas cell behavior and PDAC cell transformation. Our studies may lead to the development of a novel biomarker for early PDAC diagnosis and may reveal an ECT2 isoform switch as a novel therapeutic vulnerability in PDAC.